Toward developing a navigation model of the aging brain in the marmoset

Project Summary
The entorhinal cortex (ERC) and perirhinal cortex are the initial sites of cortical tau pathology and degeneration
in the common, sporadic form of Alzheimer's disease (AD). In the ERC, tau pathology is first seen in cell
islands in layer II, the major source of inputs to the hippocampus necessary for the formation of new memories.
Consistent with this pattern of degeneration, the earliest symptoms of AD are recent memory deficits, which
correlate with tau pathology in ERC and related synapse loss in the hippocampus. Learning what makes the
ERC so vulnerable to initial tau pathology and its basic neurobiological function is thus critical for
understanding the etiology and potential treatment of AD. Seminal studies in the medial ERC in rodents and
bats have shown that its neural activity creates a representation of the environment through a set of
functionally distinct cell types that encode various spatial and non-spatial navigational variables. Recent
discoveries of social place cells and of ERC to hippocampal pathways that carry social signals suggest that the
ERC might provide the flexible neural code to map both physical and social environments. However, there
have been no physiological studies of the marmoset ERC to determine if their functional organization is similar
to rodents and macaques. Learning about the physiology and function of the marmoset ERC is now a critical
question, as marmosets are rapidly being developed as an important primate model of AD. Studies in rodents
and macaques have shown evidence of calcium dysregulation, a major contributor to tau hyperphosphorylation,
in the aging ERC. However, the relationship of calcium signaling to grid cell physiology has not been examined.
One likely mechanism may be an enrichment of N-methyl-D-aspartate receptor (NMDAR) with GluN2B
subunits, that close slowly and flux high levels of calcium. Although there have been some elegant studies of
neuromodulatory influences on grid cell physiology in rodents, remarkably little is known about the molecular
mechanisms mediating neurotransmission in the adult ERC. Given the importance of the ERC to the early
etiology of AD and the emergence of the marmoset model to study AD, it will be essential to learn about the
healthy physiological signatures of ERC function in marmosets for comparisons to upcoming genetic models.
Understanding the basic neurobiology will also be critical in order to use this animal model to dissect the
molecular events that render these circuits particularly vulnerable to tau pathology. Aim 1 of the proposed
research will perform the first functional characterization of neurons in the marmoset ERC by examining
whether dynamic space mapping is found in marmoset ERC and whether these maps are flexibly modulated
by social context. Aim 2 will analyze the role of NMDAR mechanisms in primate ERC physiology, an area
where little is known.

Public health relevance
Project Narrative Developing a nonhuman primate model of Alzheimer's disease (AD) is of utmost importance. While the entorhinal cortex (ERC) is impacted at the early stage of AD, we know relatively little about its function in the primate brain. Capitalizing on the architectural homology between the marmoset and the human brain, we will study the neural mechanisms of navigation and flexible spatial representations in the marmoset ERC toward developing the marmoset ERC model of AD.